Phase II of BUILDing SCHOLARS

Contact PD/PI: Echegoyen, Lourdes
PROJECT SUMMARY/ABSTRACT – OVERALL COMPONENT
The University at Texas at El Paso (UTEP) proposes to continue to strengthen, maintain, institutionalize and/or
disseminate BUILDing SCHOLARS (Building Infrastructure Leading to Diversity: Southwest Consortium of
Health-Oriented education Leaders and Research Scholars) partnerships and interventions developed in the
phase I award period. The overall goal in phase II is to enhance institutional and faculty capacities to support,
sustain, and disseminate innovative undergraduate research training and mentoring activities for students in
the US Southwest region, the majority of whom come from underrepresented groups, and to contribute to the
future diversification of the NIH funded workforce. The center aims to: (1) continue to strengthen, support, and
maintain BUILD Research and Pipeline Institution partnerships; (2) continue to strengthen, support, maintain,
and institutionalize all activities for student recruitment, research training and mentoring; (3) continue to
strengthen, support, maintain, and institutionalize professional development activities for participating faculty;
(4) continue the close collaboration between the BUILDing SCHOLARS site evaluation team and the
Coordination and Evaluation Center (CEC); (5) ensure that institutional leaders/administrators keep their
commitment to sustain successful and impactful BUILD interventions; and (6) develop and implement
innovative strategies for the dissemination of results and the most successful and impactful BUILD
interventions. A robust plan for institutionalization of the BUILDing SCHOLARS program and associated
interventions will be implemented; leading to the long term sustainability of the program including support for
undergraduate trainees on full scholarships every year after the funding period. The activities are innovative
because of the trans-disciplinary emphasis, the focus on early interventions, the use of an assets bundling
approach to overcoming educational and research training barriers, and the expansion of impacts through
implementation of a research driven curriculum and a community of practice. These innovations are allowing
the center to scale-up undergraduate research training and contribute directly to the diversification of the NIH-
funded workforce. This proposal is significant because it takes a regional approach to sustaining a multi-
institutional series of programs and activities that meet the needs of underrepresented groups concentrated in
the US Southwest on their path to becoming biomedical researchers.
Page 116
Project Summary/Abstract
Contact PD/PI: Echegoyen, Lourdes

Public health relevance
PROJECT NARRATIVE – OVERALL COMPONENT The percentage of biomedical researchers from underrepresented groups who are awarded R01 grants is far below the corresponding percentage for majority groups. The proposed aims, objectives, and activities will strengthen, maintain, and institutionalize an advanced set of sustainable programs to transform the biomedical research training of students in the US Southwest, the majority of whom are underserved and underrepresented in the biomedical sciences, with the ultimate goal of improving their competitiveness for future R01 level support. Page 117 Project Narrative